Administrative Core

ABSTRACT- ADMINISTRATIVE CORE
The Administrative Core will coordinate the scientific and administrative activities of this IPCAVD Program,
ensuring that the Projects and Cores function well together. In particular, it will be responsible for managing the
program’s financial management, program management, and coordinating Projects and Cores through scientific
meetings and communications, as well as ensuring full financial and regulatory compliance. A primary activity
of the Core will be monitoring IPCAVD progress relative to milestones and measuring this progress against
available funding to ensure resources are used efficiently. As Specific Aims, the Core will provide overall
IPCAVD management, coordination and supervision of the Program (Aim 1), ensure timely financial accounting
and reporting (Aim 2), ensure compliance with all institutional, state, and federal research and cGMP guidelines
(Aim 3), develop and implement IPCAVD communication, publication, and data sharing plans (Aim 4), and
provide statistical support for all data analyses (Aim 5). The Core will coordinate an annual meeting with an
External Advisory Committee (EAC) that will review the progress of IPCAVD Projects and Cores, and with input
from the DAIDS Program Team, provide guidance for the Program’s direction. Core staff are part of a highly
experienced and integrated management team, which will enable immediate start-up and rapid progress.
This teamwork will accelerate advancement toward the Program’s goals, thus maximizing the opportunities to
positively impact HIV-1 vaccine research in humans.